TRIM37 is a genetic determinant of racial disparity in metastatic TNBC patients

African American (AA) women presents with aggressive metastatic subtype of triple negative breast cancer
(TNBC) compared to other ethnicities and experience greater mortality rates. Although health care disparities
contribute to poor prognosis in AA women but a race-specific genetic component to TNBC disparity cannot be
ruled out. Thus, racially-segregated genetic determinant underlying TNBC disparity remains an unmet clinical
need. This project is built upon our novel findings suggesting that an oncogenic tripartite motif-containing
protein 37 (TRIM37) protein predisposes AA women to highly aggressive TNBC. We demonstrate that 1)
TRIM37 associates with metastatic phenotype and overall survival in TNBC patients, 2) TRIM37 is expressed
at higher level in the breast and TNBC tumor tissue of AA women relative to other races, 3) TRIM37-
associated single nucleotide polymorphism correlates with high TRIM37 expression in AA women, 4) TRIM37
regulates genes and pathways involved in metastasis cascade, such as promoting survival in circulation, 5) AA
TNBC cells showed increased dependency on oncogenic TRIM37 compared to non-AA TNBC cell lines in vitro
and in vivo, 6) TRIM37 depletion reduces distant infiltration and growth in metastasis murine model 7) TRIM37
inhibition using targeted nanoparticles-based delivery of TRIM37-specific antisense oligonucleotides reduces
TNBC tumor growth. Based on these findings, we hypothesize that higher TRIM37 levels in AA women gives a
would-be cancer cell a “head start” by creating a pre-metastatic niche. This hypothesis will be tested in three
specific aims. In aim 1, we will evaluate TRIM37-allelic variants, that we have already identified, through small-
scale phenotypic screen based on anoikis resistance. We will also determine the mechanism of TRIM37-allelic
variants by comparing the biological activity of TRIM37 risk and reference alleles. In aim 2, we will compare
and contrast the relative contribution of TRIM37 to TNBC metastatic potential in race-dependent manner. We
will also track association between TRIM37 and its transcriptional signatures with race, metastasis incidence,
and patient's survival using disease-free and tumor tissue from TNBC patients. In aim 3, we will compare the
metastatic potential of TRIM37-depleted and TRIM37 overexpressing race-specific breast and TNBC cells
using spontaneous metastasis murine models. Finally, we will test newly engineered TNBC selective
therapeutic platform to inhibit TRIM37 using spontaneous metastasis, race-specific patient-derived xenografts
and humanized murine models. Together, the proposed studies will demonstrate that TRIM37 is a genetic
variant associated with high TNBC risk in AA women and proof-of-concept results will establish the clinical
relevance of inhibiting TRIM37 for TNBC treatment.

Public health relevance
African American women with triple negative breast cancer have much worse clinical outcome, in terms of early relapse, aggressive metastasis and 5-year survival rate of 14% compared to 36% for other races. We have discovered race-specific single nucleotide polymorphism in TRIM37 that strongly correlates with high TRIM37 expression in African American women, and aggressive metastatic phenotype. This project will demonstrate that TRIM37 is a genetic variant associated with high risk of metastatic TNBC in African American women and generate proof-of-concept data to treat metastatic TNBC using TRIM37-specific antisense oligonucleotide and investigational clinical anti-FOLR1 antibody-guided nanoparticles.